Engineered Biotherapeutic Agent for Treatment of Post-Traumatic Osteoarthritis

PROJECT SUMMARY/ABSTRACT
Post-traumatic osteoarthritis (PTOA) is a degenerative disease of cartilage brought on by traumatic injury to
the articular joints. Acute joint injury is followed by severe joint pain and inflammation. This results in much
more rapid degeneration of cartilage than in other forms of osteoarthritis, due to the joint instability caused by
trauma as well as the increase in proinflammatory cytokines that accelerate degeneration. PTOA affects 5.6
million Americans, with an estimated $11.79 billion associated with direct treatment costs for its treatment.
There are no approved treatments that stop or alter the progression of the disease, and complete degeneration
of the articular cartilage can necessitate joint replacement surgery. This may require surgical revision in
approximately 10 years, a particularly undesirable outcome in younger patients with longer life expectancies.
ProViZiGen has developed a novel protein-engineered injectable therapeutic hydrogel system, HydroGEN that
forms a gel when injected into the joint space and provides sustained delivery of an anti-inflammatory and
chondroprotective therapeutic molecule. Our recent preclinical investigation in a rabbit anterior cruciate
ligament (ACL) transection model has shown that immediate delivery of HydroGEN significantly prevents the
development of PTOA after joint injury and delivery 8 weeks after the point of injury has therapeutic effects
promoting endogenous cartilage repair. In this Phase I STTR, we aim to determine stability and lack of toxicity
of HydroGEN to establish functional gelation and establish safe dosing. In Aim I, we will determine the stability
and mechanics of HydroGEN by assessing the protein’s microstructure and macrostructure, as well as its
rheologic properties as a function of temperature and time to determine its functionality as an in situ gelling
injectable therapeutic. In Aim II, we will establish the lack of toxicity and selective biodistribution of HydroGEN
in a rat model of intraarticular injection. Successful completion of these aims will prepare ProViZiGen for filing a
BLA with the FDA, with large animal PTOA model investigation (Phase II) leading to first in human trials.

Public health relevance
PUBLIC HEALTH STATEMENT Post-traumatic osteoarthritis (PTOA) is a painful degenerative disease of the joint caused by direct injury, affecting 5.6 million Americans. It is characterized by much more rapid degeneration of cartilage compared to other forms of osteoarthritis, due to the joint instability caused by trauma as well as the increase in proinflammatory cytokines that accelerate cartilage degeneration. This proposal describes the development of a novel protein-engineered therapeutic anti-inflammatory hydrogel system, HydroGEN, for the prevention and therapeutic treatment of PTOA. Successful development of this product will provide a preventative treatment for injury patients and help them avoid years of disability and pain.